EFFECTS OF EPINEPHRINE ON REGIONAL LIPOLYSIS IN MEN AND WOMEN

To determine whether mixed Beta, alpha-adrenergic stimulation of fat from upper body and leg fat in women and men compared with pure Beta-adrenergic stimulation.